Strenghthening adminsitrative reserach capacities towards a better scientific competitiveness

Program Director/Principal Investigator (Last, First, Middle): Mhenni Hayet Project Summary Institut Pasteur de Tunis (IPT) is one of the oldest and productive Tunisian research institutions. When non-governmental and foreign research funding does not exceed 10% in Tunisian research structures, this amount reaches almost 60% at IPT. However and despite this, IPT has scarcely obtained NIAID/NIH competitive findings. This is mainly due to the fact that IPT researchers have to struggle to search for opportunities and offers and to ensure submission of their projects. Indeed, grant administrators at IPT, although trying to help by knowledge gathered by their own or in the frame of short workshops, did not receive suitable trainings in NIH grants policies and financial management. Hence, the administrative burden usually falls onto the PIs’ shoulders, who instead of focusing on the scientific achievement of their projects goals, are struggling to comply with NIH scientific reporting requirements they are not trained for. This situation hinders the scientific contribution, enhances pitfalls and delays deliverables, making the success of projects very difficult and grants renewal almost unreachable. To overcome all these constraints, IPT is applying for this grant to ultimately build a dedicated office for research administration and grant management. This will be done through an appropriate long term training of two senior administrators working at IPT, who have been involved in the management of different research grants and who have some expertise with NIH rules and policies. The personnel of the office of Sponsored Projects, at University of Rhode Island, will monitor these training. Such training will be followed by attending a one-week workshop organized by the Grants Management Program (GMP) at NIAID and will allow the two trainees to fine-tune their expertise on the management of NIAID awards according to the specific needs of IPT. These two trainees will then organize in Tunisia workshops and training sessions for administrative personnel directly or indirectly involved in pre- and post award grant management. These local training will also benefit to the personnel of other research institutions in Tunisia and in the region. Finally, this grant will allow also setting up, with the help of the Virtual University, Tunis, a web based course (MOOC) on administrative management. Ultimately, this proposal will allow the IPT to constitute an office for research administration and grant management leaded by the two senior administrators trainees, ensure sustainability of knowledge and expertise and hence enhance its capabilities to obtain competitive funds and manage successfully its research projects. OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) 1

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Mhenni Hayet Project Narrative The Director of the Fogarty International Center has recently declared that low- and middle-income countries have to take ownership of their health problems. They must indeed have well-trained scientists capable of setting research priorities and producing discoveries that are relevant in the local culture and context. However, to reach this goal, LMS scientists have to get international funding to help them reduce the risks of major diseases transmission worldwide. This funding, especially from international agencies e.g., NIAID/NIH, needs administrative and financial skills and expertise that is generally lacking at research institutes like Institut Pasteur de Tunis (IPT). The aim of this project aims to empower IPT senior administrators with such expertise and skills, ensure widespread and sustainability of this gained knowledge (management of NIAID awards according to NIH policies), and ultimately help IPT scientists and researchers to enhance their capacity to get international and competitive research funds and to better focus on the success of their projects and research. OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) 1